Paneth cell heterogeneity in infection and inflammation

PROJECT SUMMARY
Crohn’s disease (CD) is a form of IBD that commonly involves small intestine, where the majority of Paneth cells
reside. As a great number of CD patients show no response or refractory to standard treatment, there is an
unmet need for new therapeutic options based on new mechanisms of action. Recent studies suggested that
defective Paneth cells may play the key role in initiating inflammation in ileal, and maybe ileocecal CD. Paneth
cells in CD patients or mouse IBD models often exhibit granule phenotypes characterized initially by Dr. Ta-
Chiang Liu, where several Paneth cell-enriched antimicrobial factors, instead of being packed into secretory
granules, are dispersed to the cytoplasm. Hypotheses relating to defective ER stress, autophagy, and secretion
have been developed to interpret these CD Paneth cell defects, however the cause-and-effect relationship
remains obscure. To date, existing studies has been treating Paneth cells as a homogeneous population. Based
on a newly developed temporally controlled Paneth cell reporter mouse model, we establish single cell
transcriptomic maps for ileal Paneth cells in homeostasis, dysbiosis, infection and inflammation conditions. We
found that there is a profound change in Paneth cell heterogeneity in response to microbiota alteration, infection,
and potentially genetic risk factors. Analyzing Paneth cell populations across different conditions revealed an
immunologically activated Paneth cell subset that has distinct antimicrobial peptide profile, enriched cytokine
receptor, and heightened innate immune and degranulation activities. Paneth cells carrying the signature
markers are found in ileal CD and UC metaplastic lesions. We will test the hypothesis that a dynamic Paneth cell
heterogeneity regulated by interactions of genetic, gut microbiota, and environmental factors such as pathogen
infection is critical for activation of Paneth cell-mediated innate protection against inflammatory induction and
aggravation. Aim 1 will determine the function and disease relevance of these Paneth cells by examine their
innate immune function, degranulation capacity, chromatin and epigenetic profile, in vivo role of specifically
secreted mucosal pentraxins, and relevance to CD Paneth cell defects and clinical outcomes. Aim 2 will test how
two Paneth cell intrinsic pathways and CD dysbiotic microbiota affect Paneth cell heterogeneity, by performing
Paneth cell specific genetic ablation and overexpression, as well as fecal microbiome transplantation in newly
developed germ-free Paneth cell reporter mice. This proposal addresses a significant and innovative hypothesis
relating to Paneth cell heterogeneity that may contribute to the causality and mechanism of Paneth cell-driven
CD pathogenesis. Once a new mechanism regulating proper Paneth cell activation and inflammatory protection
is identified, it may be leveraged for IBD intervention.

Public health relevance
PROJECT NARRATIVE This project tests a hypothesis that interaction of genetic and environmental risks such as pathogen infection impair Paneth cell heterogeneity and induction of proper innate immune response, which are vital for protecting against intestinal inflammation. The project will combine genetically engineered mouse models, pathology analysis of Crohn’s disease patient tissues, and microbiome association in gnotobiotic mice to investigate how healthy vs. dysbiotic microbiota differentially affect Paneth cell populations, IBD initiation and progression.